Control of Opioid Receptor Signaling and Pharmacological Tolerance through Endosomal Recycling and Retromer

Project Summary
Opioids play a frontline role in acute pain management in the clinical setting. Prolonged use of opioids
causes multiple adaptations including tolerance—a phenomenon in which increasing opioid dosage is required
to maintain drug efficacy. The pharmacological component of opioid tolerance is largely driven on the cellular
level and is the result of cellular protein networks terminating the activity of the mu opioid receptor (µOR). A
critical step in this regulatory process is membrane trafficking. High efficacy opioids cause the µOR to rapidly
traffic from the cell surface to internal cellular structures called endosomes. At endosomes, the µOR is either
sorted back to the cell surface for continued activity (resensitization) or sent to the lysosome for destruction
(downregulation). A long-standing model is that downregulation can drive pharmacological opioid tolerance
through proteolysis of opioid receptors outpacing new receptor synthesis. One challenge in testing this model
is that we don’t know the identity of key cellular protein networks regulating mu opioid receptor trafficking at
endosomes.
Here we leverage our recently developed proteomic and genomic methods for identifying cellular
proteins which regulate opioid receptors. In Aim 1 we focus on the trafficking of the µOR at endosomes and,
using biochemical and cellular techniques, test the hypothesis that the endosomal Retromer complex rescues
mu opioid receptor from lysosomal degradation in a process called recycling. We will use functional genomics
to identify potential druggable targets—kinases and ubiquitin-ligases—that regulate µOR through endosomes,
and test the related hypothesis that opioid-induced downregulation of the µOR can be blocked by engineered
“super-recycling” variants of the receptor. In Aim 2 we test the hypothesis that endosomal recycling and the
endosomal Retromer complex controls three different phases of µOR signaling: endosomal signaling,
resensitization, and the development of pharmacological opioid tolerance at the cellular level. Together, these
studies seek to define a critical regulatory process controlling µOR function and identify cellular proteins which
could be targeted to control the development pharmacological opioid tolerance.

Public health relevance
Project Narrative Opioids are highly useful analgesics but repeated opioid use causes physiological adaptations including tolerance and increased risk from harmful opioid side-effects. Pharmacological tolerance arises in large part from cellular protein networks which regulate the target of opioids, the mu opioid receptor. Here we investigate the role of endosomal proteins in controlling mu opioid receptor function and the development of pharmacological tolerance to opioids on a cellular level.